Acculturation, Social Context, Loneliness, and the Development of Alcohol Problems in Latinx Individuals

PROJECT SUMMARY
Loneliness is a psychological state arising from a discrepancy between perceived and desired social connection.
It is a significant risk factor for health concerns, including problematic alcohol use. Crucially, Latinx individuals in
the US experience greater loneliness than non-Latinx White individuals, and those who drink engage in more
problematic alcohol use. However, the initial precursors of loneliness and Latinx disparities in loneliness are not
well-understood. Moreover, it is unclear if loneliness is a cause of alcohol problems, a consequence of alcohol
problems, or a barrier to recovery. The objective of this application is to identify predictors of loneliness in Latinx
individuals and explain the link between loneliness and the development of problem drinking in this population.
We will evaluate a novel process model that explains loneliness and the development of alcohol problems in
Latinx individuals. The ALMA Process Model states that social contextual factors interact with Acculturative
Processes to predict Loneliness, Drinking Motives, and Alcohol Problems. The central hypothesis of this
research, guided by the ALMA Process Model, is that conflicts between Latinx individuals' cultural orientation
and the cultural orientation of those around them contribute to decreases in perceived social connection, leading
to loneliness. When feeling lonely, some people increase solitary drinking to cope with loneliness. Drinking to
avoid an aversive state will lead people to focus more on that state, exacerbating people's feelings of loneliness.
Over time, more solitary drinking will feed back into the experience of loneliness, leading to escalations in
problematic alcohol use. Three specific aims will provide structure for evaluating this model: (1) To identify short-
term predictors of loneliness and alcohol use in hazardous-drinking Latinx individuals; (2) To determine how
loneliness and hazardous drinking lead to the longitudinal development of alcohol problems in Latinx individuals;
and (3) To test the reciprocal influence of hazardous drinking and the development of alcohol problems on
loneliness trajectories over time in Latinx individuals. Aims will be accomplished using a longitudinal ecological
momentary assessment (EMA) “burst” design among 200 hazardous-drinking Latinx individuals from the
community. The EMA bursts will occur semi-annually at 0, 6, 12, 18, and 24 months. Data will be collected via
self-report, cognitive-behavioral task, wearable alcohol sensor, and geotagging. This project is expected to
contribute detailed conceptual information about the mechanisms, processes, and trajectories involved in social
connectedness and isolation. By evaluating the innovative ALMA process model, this research will provide a
formal explanation for Latinx disparities in loneliness and alcohol problems. Furthermore, this model is expected
to have broad impact because it is applicable to many health disparity populations (e.g., first-generation college
students, sexual and gender minority individuals). Explaining the source of loneliness in these diverse groups
will be a critical step toward mitigating loneliness and improving population health.

Public health relevance
PROJECT NARRATIVE Latinx individuals in the US are lonelier than non-Latinx White individuals, and Latinx individuals who drink consume more alcohol, engage in more hazardous drinking, and experience disproportionately greater alcohol problems than White individuals who drink. This project will identify precursors of loneliness in hazardous- drinking Latinx individuals and explain the link between loneliness and the development of problem drinking in this population. This research will fill an important gap in explaining the underlying social-cognitive, behavioral, interpersonal, and cultural mechanisms contributing to loneliness and alcohol problems in Latinx individuals, and it will have broad application to many additional health disparity populations.